Latino Scholars in HIV/AIDS Research Education (SHARE)

Abstract
Latinos (used throughout proposal as inclusive of all genders) have become the largest ethnic minority group in
the United States but the rapid growth of the Latino US population has yet to translate into a significant
increase in Latino researchers and/or health professionals. Through the research workforce diversity objective
of the NIH research education program, R25 (PAR-19-197), the Latino-Scholars in HIV/AIDS Research
Education (SHARE) Program at The George Washington University, grounded in Social Cognitive Career
Theory and Intersectionality Framework, seeks to address both the shortage of Latino investigators in the field
and to improve the quality of Latino HIV scientists. This objective will be achieved by the following aims: Aim 1.
Develop a competency-based approach to mentoring with a triad of integrated mentors (i.e., career, science,
and peer) in HIV/SUD (Substance Use Disorder), and assess cognitive-related mediators (i.e., self-efficacy and
science identity) of mentoring effectiveness and career success. Aim 2. Implement activities for 30
participants (six undergraduate Latino participants per year over five-year project period) for mentored hands-
on research experience (prospective research study or secondary data analysis) on a high-priority focused
HIV/SUD research topic (Health inequities, social determinants of health, prevention and care continuum, and
comorbidities). Aim 3. Implement activities for educational and professional-career enrichment experiences
through didactics and professional-career enrichment seminars. For these program aims, we will evaluate the
impact and effectiveness of SHARE Program on outcomes achieved and career trajectories of the participants
and disseminate program success. Expected short term outcomes will include promoting development of a
cadre of undergraduate Latino students committed to pursuing behavioral, social and health science research
careers in HIV/SUD. The long-term outcome and impact of the program aligns with the priority of the National
Institute of Drug Abuse (NIDA)--to increase diversity, in number and quality, of well-trained researchers in the
behavioral and social sciences of HIV and SUD, to reduce their societal consequences and improve individual
and public health.

Public health relevance
Project Narrative Latinos are the largest and fastest growing ethnic minority group in the U.S., yet they are significantly underrepresented at all levels of appropriate academic programs critical for entry to health profession careers. Through an intensive summer training program, the Latino Scholars in HIV/AIDS Research Education (SHARE) at The George Washington University will enable undergraduate students to attain advanced education in behavioral-social science research of HIV and substance use disorders. The expectation is to facilitate their success in future academic and research endeavors, further promote educational and career opportunities in critical STEM fields, and enhance diversity of the research workforce.